Enhancing Gamma Band Response in Schizophrenia to Improve Working Memory

ABSTRACT
Schizophrenia (SCZ) is a chronic debilitating mental disorder that affects 2.4 million Americans and
leads to considerable individual and societal costs. In patients with SCZ, cognitive deficits (CD) occur early in
the course of the illness, are associated with more severe illness, and are the best predictor of functional
outcomes. Nonetheless, to date, CD have been difficult to treat using available treatments. Recent studies
suggest CD in patients with SCZ may arise from abnormal synchronization of distributed neural networks.
Synchronization or synchronous firing of neurons, binds cortical areas into functional networks in a task and
state-dependent manner. Thus novel therapies that improve abnormal neural synchrony may improve
previously refractory symptoms arising from disordered brain networks.
Neural synchrony in the gamma band (GBR, 30-45Hz) plays a central role in top-down attention,
multisensory processing, perceptual binding and working memory (WM). Patients with SCZ exhibit abnormal
GBR, and the magnitude of impairment is associated with the severity of cognitive disorganization. Given these
results, improving GBR should improve CD, including WM in SCZ. This hypothesis has been tested and
confirmed using repetitive transcranial magnetic stimulation (rTMS). Additionally, EEG-based neurofeedback
(NFB) is hypothesized to improve GBR and cognitive function in patients with SCZ. NFB is a low-cost, easily
administered and well-tolerated treatment. In healthy controls, Gamma-NFB improves GBR and cognitive
function including WM. Thus, we propose testing the feasibility and effectiveness of improving GBR using
gamma-NFB in patients with SCZ using the framework of the R61/R33 mechanism.
The first trial (R61) is a proof-of-concept study designed to assess target engagement and dose
response curve. Thirty SCZ patients will receive G-NFB training for 20 weeks (2 weekly sessions of 30minute
duration) and be assessed for 1) evidence of training, 2) Change in GBR, 3) Change in WM and 4) Change in
community functioning. The second trial (R33) aims to confirm target engagement based on training
parameters obtained from R61, and to assess whether G-NFB is superior to an active-placebo neurofeedback
intervention in improving GBR, WM and community functioning.

Public health relevance
Schizophrenia affects 2.4 million Americans and causes significant individual and societal costs. Cognitive deficits including poor working memory arise early in the course of illness, account for poor long-term outcomes and have been difficult to treat with available treatments. We are proposing to develop a novel, computer-based brain training to improve working memory in schizophrenia patients, which, if successful could have significant personal, societal, and economic impact.